CORE--DEVELOPMENT FUNDS

Description: Developmental Funds support of $250,000 is requested, with $170,000 per year for support of investigators newly recruited to USC whose research interests complement and strengthen the Cancer Center research programs, and $80,000 per year in pilot project funds to support four projects of $20,000 each per year.